Core D: External Research and Dissemination Core

Project Summary:
Abstract
This new proposed Core will support the work of the “Collaborative for Innovation in Data & Measurement in
Aging” (CIDMA) a collaboration of researchers at the University of Chicago (UChicago) Center for Healthy Ag-
ing Behaviors and Longitudinal InvestigationS (CHABLIS)and the Duke Center for Population Health and Aging
(CPHA). This Collaborative Core will identify, design, conduct and assess innovations in data collection and
measurement for use in current and future data-focused studies of aging. These innovations in data collection
and measurement will be focused on the following issues: (a) adapting methods for measuring cognition and
brain functioning from laboratory to field settings; (b) extending place-based studies of activities of individuals
and their consequences for health and well-being from urban to rural settings; and (c) assessing ways to im-
prove the collection of survey data and data from health records in both hospital- and population-based set-
tings, with special emphasis on developing methods to improve subject recruitment and retention and the use
of adaptive consenting processes to establish trust. The assessments conducted by CIDMA will have rapid
turnaround, from design to dissemination of its findings (thus, we refer to them as Rapid Assessments). These
Rapid Assessments will be focused on developing measures and methods that are cost-effective and that can
be implemented in a range of settings, especially those “in the field” for population-based studies. The mem-
bers of CIDMA will work collaboratively on these tasks, drawing on both their particular expertise and experi-
ence in data collection in studies of aging. This Core also will disseminate and educate the research commu-
nity on its findings. It will maintain an on-going dissemination effort of its findings and create a dialogue be-
tween researchers and survey operations professionals, and their application to existing and future studies.
This Core also will conduct two summer institutes and an end-of-project symposium/workshop to train and edu-
cate the next generation of researchers and data collection professionals in the study of aging.
1